Flavivirus immunity in endemic and non-endemic human cohorts

PROJECT SUMMARY
The global spread of the arthropod borne flaviviruses dengue (DENV1-4) and Zika (ZIKV) viruses are major
global public health challenges. World health organizations are calling for scientific communities to respond to
this emerging threat with vaccines, therapeutics and diagnostics. However, existing gaps in fundamental
knowledge about DENV and ZIKV immunity, specifically how type-specific immunity to each serotype develops
and is sustained, makes rational vaccine development particularly difficult. The dominant immunity model comes
from human challenge studies on DENV (1910’s-1940’s) and posits that first infection induces neutralizing
antibodies that provide life-long sterilizing immunity to repeat infections by the same (homotypic) serotype virus,
and this model has been extended to ZIKV without rigorous evaluation. However, recent studies from DENV
endemic regions provide evidence of homotypic re-infection and natural immune boosting over time and our
preliminary data from a non-endemic, Portland, Oregon resident DENV and ZIKV immune cohort show type-
specific Abs decay – lose both potency and breadth - over time, calling into question sterilizing immunity and
leading us to hypothesize that natural flavivirus (ZIKV and DENV) protective immunity is context dependent: in
endemic transmission settings intermittent asymptomatic boosting maintains potency and breadth of virus
specific immunity and in non-endemic or very low transmission settings potency and breadth of flavivirus
immunity significantly wanes. To test this hypothesis, we propose to prospectively characterize and compare
DENV and ZIKV immunity in a regularly re-exposed endemic cohort in Ponce, Puerto Rico with immunity in an
un-boosted, non-endemic cohort of DENV immunes in Portland. This is a controversial and novel hypothesis
that will call for substantial supporting evidence, hence we will compare and contrast three highly relevant and
related markers of boosting between the two cohorts: The potency and breadth of neutralizing serum DENV and
ZIKV specific Abs (Aim 1), the frequency of and potency of DENV and ZIKV non-structural protein 1 (NS1)
specific antibodies (Aim 2), and the frequency and specificity of DENV and ZIKV specific memory B-cells (MBCs)
(Aim 3). We expect to find that Abs and MBCs decline at a significantly greater rate in individuals from the non-
endemic setting compared to the endemic setting supporting the hypothesis that boosting plays a critical role in
natural immunity for these viruses, with implications for future vaccine development. Because MBCs are
functionally linked to Abs, quantifying virus specific MBCs tests a mechanistic connection between repeat
infection and Ab titer boosting. Our proposed work will comprehensively assess the role transmission context
plays in flavivirus immunity using two highly relevant and mechanistically linked determinants (Ab and MBC).
Irrespective of specific results, the knowledge obtained from the proposed work will be essential to DENV vaccine
development and mechanistic understanding of flavivirus Ab mediated immunity.

Public health relevance
PROJECT NARRATIVE The proposed research evaluates DENV and ZIKV immunity in humans living in endemic and non-endemic settings. This knowledge is critical to understanding the potency, breadth, determinants and correlates of ZIKV and DENV immunity as well as effective evaluation and improvement of this vaccine that is critical to control this globally important disease. The results of this project are highly and directly relevant to the NIH’s mission fostering innovative research strategies to reduce the burden of illness and disease.